Early Drivers of Humoral Immunity to SARS-CoV-2 Infections

Abstract
The duration and nature of humoral immunity to SARS-CoV-2 (CoV2) infection need to be better
understood. While most studies have focused on the immune response in patients with clinical illness,
little is known about the antibody response to CoV2 immediately after exposure and before the onset
of illness, especially in asymptomatic individuals. It is important to understand how this impacts long-
term immunological memory. This supplement aims to extend the objectives of the original grant to
address these gaps in our knowledge by prospectively following household contacts compared to
clinical cases of CoV2 to determine innate and adaptive immune events associated with early viral
exposure. We have conducted a comprehensive evaluation of samples from these patients, including
RNA sequencing of peripheral blood cells, proteomic analysis of oral secretions (the site of initial
CoV2 replication), measurement of viral load using N protein levels, and CoV2-specific IgA and IgG in
blood and saliva. We have identified innate and adaptive signatures associated with viral clearance
and among household contacts that may be associated with their failure to be infected or, if infected,
fail to develop clinical illness. We have identified CoV2 antigens, notably the N protein that is
expressed on CoV-2 infected cells, which are targets of ADCC. Antibodies generated by the N protein
can similarly kill infected cells with various variants of concern, suggesting a potential variant-
transcending target. We have also tracked the humoral immune response in a long-term cohort of
nursing home residents to the CoV-2 mRNA vaccine and subsequent booster responses. This
supplement will continue these ongoing studies and allow their completion.

Public health relevance
Narrative The duration and nature of immune response to SARS-CoV-2 (CoV2) infection, especially in asymptomatic individuals, needs better understanding. This supplement continues the overall objectives of the original proposal to follow household contacts with clinical cases of CoV2 to determine immune events associated with early viral exposure. The study will evaluate innate and adaptive immune responses and their correlation with viral clearance and the development of effective immunity and long-term memory. The research will also examine the relationship between early immune response and long-term immunity, and develop serological tests based on these findings.